PLASMA AMINO ACIDS &GLUCAGON RESPONSE TO INSULIN INDUCED HYPOGLYCEMIA

To investigate the relationship between infusion of amino acid solutions and increased secretion in response to insulin induced hypoglycemia in normal subjects.